CaMKII and Endothelial SK Channel Function in Diabetic Coronary Microcirculation

Summary/Abstract
Patients with diabetes mellitus (DM) manifest coronary microvascular endothelial dysfunction, characterized by
impaired endothelium-dependent relaxation. Impaired endothelium-dependent vasodilation decreases coronary
blood flow and myocardial perfusion, resulting in cardiac dysfunction/diabetic cardiomyopathy, and myocardial
ischemia with no obstructive arteries (INOCA), which increase morbidity and mortality in the diabetic population. Our
recent studies indicate that dysfunction of small-conductance calcium-activated potassium channels (SK channels)
play a key role in DM-induced endothelial dysfunction in animal and human coronary microcirculation. However, the
mechanisms responsible for diabetic dysregulation of endothelial SK channels and coronary microvasculature
remain undefined. Our pilot data indicate that DM causes excessive phosphorylation of CaMKII (p-CaMKII), O-
GlcNAcylation of CaMKII (OG-CaMKII), and oxidation of CaMKII (ox-CaMKII), along with increased mitochondrial
ROS (mROS) production in the heart and endothelial cells. Moreover, our preliminary studies demonstrate that
chronic p-CaMKII, ox-CaMKII and O-GlcNAcylation during DM reduce endothelial SK channel activity, or coronary
microvascular relaxation, and/or myocardial blow flow in both male and female mice. These results suggest that
CaMKII posttranslational modification plays an important role in diabetic dysregulation of endothelial SK channels,
coronary microvascular function and myocardial perfusion. Thus, the overall goal of this project is to investigate
how CaMKII posttranslational modifications during chronic DM alter endothelial SK channel activity, coronary
microvascular endothelial-dependent relaxation, and myocardial blow flow. Our central hypothesis is that sustained
and excessive posttranslational modification of CaMKII during chronic DM dysregulates endothelial SK3/SK4(IK)
channel activity, eNOS signaling, and endothelial function, resulting in coronary microvascular dysfunction and
myocardial hypo-perfusion. We will test our hypothesis by employing multiple innovative approaches from
cellular/molecular analyses and microvascular biology to physiology and pathophysiology. These approaches
include type-1 and type-2 diabetic mouse models in combination with knock-in mouse models of oxidation-resistant
CaMKII (MMVV), O-GlcNAcylation-resistant CaMKIIδ (S280) and a transgenic mouse model of endothelial cells
expressing synthetic CaMKII inhibitory peptide (AC3-I) in both male and female animals, as well as endothelial ion
channel recordings by patch clamp methods, measurement of microvascular reactivity in-vitro by a vessel
myograph, contrast echocardiography to measure myocardial blood flow reserve in-vivo, immunoprecipitation (IP),
LC/MS-MS, and site-directed mutagenesis, amongst other methods. The impact of gender differences on diabetes
induced CaMKII posttranslational modification and related coronary microvascular dysfunction will also be analyzed.
This integrated proposal will result in the identification of novel pathways, molecular targets, and novel therapeutics
strategies for improving coronary microvascular function in diabetic patients with coronary heart disease.

Public health relevance
Project Narrative Coronary microvascular/endothelial dysfunction associated with coronary heart disease increases morbidity and mortality in the diabetic population. This project investigated the underlying mechanisms by which CaMKII posttranslational modifications during diabetes mellitus dysregulate the small conductance calcium-activated- potassium channels, alter coronary endothelial/microvascular function, and affect myocardial perfusion. This integrated proposal will result in the identification of novel pathways, molecular targets, and novel therapeutics strategies for improving coronary microvascular/endothelial function in diabetic patients with coronary heart disease.